Control of the Hippocampal Formation by the Supramammillary Hypothalamus - Anatomy Physiology and in a Model of Medial Temporal Lobe Epilepsy

PROJECT SUMMARY/ABSTRACT
Epilepsy affects 3.4 million people in the US, with medial temporal lobe epilepsy (MTLE) the most common type.
The dentate gyrus (DG) is central to the pathophysiology of MTLE. The DG becomes hyperexcitable in MTLE
due to the loss of DG inhibitory interneurons and an increase in the number of recurrent synapses of DG granule
cells (GCs) resulting positive excitatory feedback. While activation of DG inhibitory interneurons can have an
anti-seizure effect, these are lost in MTLE and driven by GCs, urging us to examine an alternative mechanism
to control the DG. Surprisingly, the DG has few inputs. The entorhinal area conveys information from the cerebral
cortex and is excitatory. The septal area and SuM are similarly large inputs, but the septal area acts indirectly
on GCs by way of inhibitory interneurons that are lost in MTLE. The SuM, by contrast, directly innervates GCs,
including with highly unusual neurons that release both GABA (an inhibitory neurotransmitter) and glutamate (an
excitatory neurotransmitter). The role of these neurons is unclear, and, unlike other SuM neuronal types, these
GABA/glutamate neurons do not promote wakefulness or theta EEG activity. Preliminary data reveals that
disruption of GABA release from these neurons results in high mortality in mice that were not monitored with
video/EEG, and a low-voltage abnormal EEG in intermittently monitored mice, both consistent with established
status epilepticus. The central hypothesis of the proposed studies is that these SuM GABA/glutamate neurons
stabilize the DG and provide a promising selective target for the treatment of MTLE. Aim I will delineate the input
and output relations of SuM neuronal groups, helping to understand the circuit basis for SuM effects and SuM-
hippocampal interactions. Aim II will examine the effects of disruption of GABA release from SuM
GABA/glutamate neurons (using the Cre/lox technique), chronically recording video/EEG and hippocampal field
potentials, with the hypothesis that the mice will develop spontaneous seizures arising in the hippocampus, and
progress to status epilepticus. Aim III will examine the effects of chemogenetic activation of SuM
GABA/glutamate neurons on the frequency and severity of spontaneous seizures in the intra-amygdala kainate
model of MTLE. Overall, these studies will provide an improved understanding of SuM-DG interaction in normal
physiology and MTLE, providing a potentially specific modulatory target for the treatment of MTLE.
These studies will provide key training and career development experiences enabling the applicant to reach the
career development goal of becoming a rigorous and successful independent physician-scientist studying the
systems neuroscience of epilepsy. The mentorship team has well-established expertise in mentoring junior
faculty, and will provide training in epilepsy basic science, neuroanatomy, electrophysiology, vectors and
chemogenetics, as well as in the preparation of grants and manuscripts. The Career Development plan includes
training in the responsible conduct of research, statistics, design and reproducibility, signal processing, as well
as conference attendance enabling career development training and the communication of scientific work.

Public health relevance
PROJECT NARRATIVE The proposed work has clear public health relevance by studying the most common type of epilepsy, medial temporal lobe epilepsy, accounting for about a million cases of epilepsy in the US alone. Presently, many people with temporal lobe epilepsy continue to have uncontrolled seizures, despite the best present treatments, and the present work aims to study a novel and potentially selective therapeutic target. The project is relevant to the mission of NINDS by combining scientific enquiry, contribution to our fundamental understanding of the neurobiology of an important medical disease, and the use of this information to alleviate the burden of suffering by the exploration of new approaches to the study and treatment of this disorder.